Developing a High-Flow Acoustofluidic Loading Platform for Research Cell Stabilization in the Anhydrous State

Project Summary
Model cells for cancer research and drug discovery are currently stored using cryogenic methods that
necessitate powerful freezers and liquid nitrogen. Frozen cells require regular upkeep, have high energy costs,
take up a lot of space, and rapidly degrade if cooling devices fail. Efforts to develop a lyophilization protocol for
model cell lines have been ongoing for decades, however, loading protective agents into nucleated cells has
proven challenging. DesiCorp has developed a novel and innovative cell loading device, termed the high flow
acoustofluidic loading (HFAL) that can deliver protective osmolytes, proteins, and nucleotides into eukaryotic
cells. Unlike microfluidic loading techniques, HFAL uses large channel dimensions that allow substantially
larger volumes of cell suspension to flow through it at once. The cells are mixed with cationic lipid-coated
microbubbles that resonate with ultrasound waves, inducing cavitation. These cavitation-induced microjets
physically inject compounds from the surrounding media into the cells in suspension, which then repair any
membrane damage and seal membrane-impermeant compounds inside of the cell. This technology has
previously been utilized to load human erythrocytes with protective compounds, allowing them to be
lyophilized, stored at ambient temperatures, then rehydrated with over 90% cell recovery. A notable innovation
of the HFAL platform is the ability to load cells at high rates, exceeding 500 billion erythrocytes per minute.
However, the unique challenges of protecting organelles requires additional work to design and validate the
HFAL platform for eukaryotic cell stabilization during lyophilization. The specific aims for this proposal are 1) to
develop a complete, sterile acoustofluidic loading system that loads HepG2 and HEK 293 cells with over 60%
cell recovery, which will be measured using trypan-blue exclusion; 2) to achieve compound loading into HepG2
and HEK293 that is sufficient for their stabilization in the desiccated state, which will be measured using
enzymatic and colorimetric assays; and 3) to lyophilize HepG2 and HEK293 cells, store them at ambient
temperature, and rehydrate them with high enough recovery for culturing and their organelle structure should
resemble that of frozen and thawed model cells, which will be measured using fluorescence microscopy. The
main criterion for success of this phase I proposal is the fabrication of a fully integrated acoustofluidic loading
platform that successfully loads eukaryotic cells with protective agents that allow them to be lyophilized, stored,
rehydrated, and cultured. Lyophilized cell stocks have several advantages over cryogenically preserved cells,
such as the lack of ongoing maintenance and energy costs. Large storage devices, such as freezers or liquid
nitrogen dewars, are unnecessary for lyophilized products because they are thermally stable. If this proposed
work is successful, then cell stocks could be stored in drawers, binders, or even with the notebooks detailing
their creation, modification, and data associated with grants or publications.

Public health relevance
Project Narrative Experiments using model cancer cells are a critical step for researchers developing novel drugs and cancer treatments. These cells are very valuable and must be kept for years in order to replicate experiments, but storing them is expensive and uses a lot of space. If these cells can instead be loaded with preservatives using our ultrasound technique, then they could be freeze-dried and stored without expensive equipment or power requirements, which would help make cell research more accessible, affordable, and reproducible.